Developing Technology to Remotely Measure Molecular Composition

There is a critical need for accurate and safe early stage detection of, e.g., infectious diseases, hazardous materials, and other
health related issues. Remote detection directly from surfaces, especially related to health concerns (in situ, in vivo) is an
underserved area of immense utility. Thus, significant commercial opportunities exist because of the dearth of these
capabilities as “demonstrated” in the current double pandemics of Covid and drugs as well as persistent threats (bacterial,
fungi, cancers, bioagents, etc.). Mass spectrometry (MS), because of its ability to detect hundreds of biological compounds
in a single acquisition provides the capability to distinguish chemical differences associated with, e.g., different pathogens
and disease states, as well as target specific compounds in or on surfaces or within compositions (e.g., drugs from Skittles),
as examples. Current MS approaches use ionization methods requiring user expertise and frequently specialized
instrumentation, which significantly increases cost. Over the past 30 years, mass spectrometers have undergone a
renaissance in their cost-to-capability ratio. For more widespread applications of MS in advancing healthcare, there is a
need for new advanced direct sampling / ion source technology that provides for minimal user intervention and long-term
use without maintenance. These attributes are necessary if testing of hundreds of individual surfaces daily per instrument to
e.g., identify, track, and contain the spread of infectious agents, or to detect cancer in biopsied tissue or cancer boundaries
during surgery is to be implemented using MS in the future. The goal of this NIH SBIR Phase I project is to demonstrate
that an entirely new sampling device-transfer-ionization approach constitutes a disruptive technology and effective method
that can be used for the next-generation disease detection and health management. The basic invention of this project is
covered by two MSTM provisional patent applications (April 3 and June 5, 2023), and earlier IP from inventors Trimpin
(CEO of MSTM) and McEwen (President of MSTM) exclusively licensed from two universities to MSTM. In summary,
these developments and remote sampling research position MSTM well for advancing this exciting area in need of new
technology. Critical advantages include exceptional ease and flexibility, on the fly results, remote sampling of 3-
dimensional surfaces without and with the use of a laser, robustness to instrument contamination and carryover, and the
capability to retrofit with commercial atmospheric pressure ionization mass spectrometers to provide accurate, safe,
detection on demand. The objective of this Phase I project is to demonstrate the feasibility and proof-of-concept of the
surface reader to sample surfaces directly with a liquid meniscus or indirectly by laser ablation. In Phase II, an FDA
approved CO2 laser will be implemented along with machine learning algorithms in a commercial product requiring little
expertise to effectively operate. Aim 1: Build a proof-of-concept remote surface reader interfaced with an MSTM multiport
inlet using SAI and VSAI MS for differentiation of diseased vs. normal tissue through computer aided m/z fingerprint
recognition. Aim 2: Test the remote transfer device of Aim 1 using real samples for demonstration and Phase II purposes.
MSTM has the necessary expertise and facilities to bring this Phase I project to a successful conclusion within 12 months.
MSTM has enlisted help from knowledgeable companies (letters Advion, Bruker, Medtronic, Thermo, BioPharmaSpec).

Public health relevance
Project Narrative The critical need for early and direct detection (in situ, in vivo) of a rapidly spreading and previously unknown infectious agent was made clear by viral (SARS-CoV-2) and drug pandemics (oxycodone, fentanyl) as well as notorious diseases (cancers, Alzheimer’s), fungal and bacterial infections with nearly instantaneous and accurate results saving or improving many lives. Current results are too slow, inaccurate, insensitive, expensive, or simply not applicable to safely and directly detect a wide range of infectious agents and diseases on demand and nearly instantaneously, thus providing significant commercial opportunities for mass spectrometry (MS) instrumentation capable of doing this directly from 3- dimensional surfaces, and, when necessary, with spatial resolution achieved by incorporation of a laser. MSTM is developing an MS-based surface reader product to meet this challenge by 2027 with the potential to significantly lower cost through simpler, information rich, robust, and user-friendly technology in combination with artificial intelligence programs.